Tracking the onset of spatial memory deficits in aging and Alzheimers disease models with single neuron resolution electrophysiology

Project Summary/Abstract
Aging changes the adult brain both structurally and functionally. Something about these changes promotes
cognitive decline and increases the risk of Alzheimer's disease, a neurodegenerative disease that affects millions
of Americans and is the leading cause of dementia among adults. I propose to carry out longitudinal
electrophysiology and behavioral studies to understand how age-related changes in individual neurons and their
circuits contribute to cognitive impairments in mouse models of aging and Alzheimer's disease. I plan to take
advantage of a novel biotechnology, mesh electronics, that will overcome many previous challenges preventing
the study of aging processes of single neurons and their circuits. I will use this technology combined with
behavioral tasks in virtual reality to understand how neurons and their circuits within the hippocampus and
entorhinal cortex change with normal aging and lead to cognitive decline. Then I will perform similar studies to
understand how spatial memory and learning deficits arise in a model of aging in Alzheimer's disease that
expresses pathological tau, with the goal of determining if either soluble or aggregated tau leads to neuronal
dysfunction and spatial memory impairment or if they arise coincidentally. These data will be extremely valuable
for the medical community as aggregated tau is currently the target of several ongoing clinical trials. These
experiments will also establish mesh electronics as a useful tool for the study of normal and pathological aging
that could be extended to understand the onset of cognitive decline in many other model systems.

Public health relevance
Project Narrative These experiments will provide insight into processes that contribute to cognitive decline with aging and Alzheimer's disease. I will look at how neurons and their circuits change with age and try to determine which features are harmful and which features are coincidental. These data will help understand what form of the protein tau, a pathological hallmark of Alzheimer's disease, should be targeted by clinical trials to treat cognitive decline in Alzheimer's disease.